Immunology core

Summary of Immunology Core:
The immunology core will provide expertise in data generation and analysis for all immunological
studies as part of the Asia Pacific ICEMR. This core will interact closely with the investigators of
all three Asia Pacific ICEMR projects and generate state-of-the-art immunology data to
complement the research objectives. In addition, the Immunology Core will coordinate its activities
with the Data Statistics and Modelling Core to facilitate integration and sharing of immunology
data generated among investigators. We already have extensive experience with all experimental
procedures described in this application and many of the assays have already been successfully
applied to malaria parasite species. In collaboration with the Data Statistics and Modelling Core,
the Immunology Core will also implement strategies to facilitate the use of the data generated by
the Asia Pacific ICEMR investigators and the broader community. In particular, we will make the
immunology data from the study quickly available to others by developing an immunology data
sharing platform with other ICEMRs. This will greatly facilitate querying and exporting subsets of
the data or set of samples and speed up analyses. These browsers will be publically available to
any researcher outside the Asia Pacific ICEMR immediately upon publications.